Agile development of innovative, interactive hazard recognition and mitigationtools/learning e-platforms for workers involved in the rescue and recovery operations indiverse flooding environments

ABSTRACT Flooding events continue to increase in both frequency and intensity. Workers involved in post-flood reconstruction work are at increased risk of adverse health effects due to respiratory exposures and other hazards. Proposed e-learning platform “Pocket Ark” provides training before flooding occurs, real-time decision support during a clean-up, and communications capabilities during and after cleanup to the workers involved. It addresses an important public health problem and uses a novel app-based e-learning platform to improve and enhance the cognitive understanding of flood-related health hazards within this vulnerable working population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the safety of individuals participating in post-flood reconstruction is becoming increasingly more important in terms of the number of workers involved in this activity and the number of hazards they are exposed to in the aftermath of storms of increasing intensity.